Defining the partner interaction network of the tetraspanin CD53 in regulating B cell trafficking

Project Summary/Abstract
The goal of this project is to understand how CD53 regulates B cell trafficking, and to determine the CD53-
partner network underlying this process. CD53 is a member of the tetraspanin family of transmembrane proteins
that organize multi-protein networks on the cell surface to regulate a wide variety of cellular processes such as
proliferation, homing and survival. Loss of CD53 is associated with impaired immune system function. CD53 is
highly expressed on both normal and malignant B cells, however its role in these cells is not clear. We previously
reported that CD53 is required for normal B cell development in the bone marrow. In preliminary data, we now
find that CD53 is essential to both normal and malignant B cell trafficking, with the loss of CD53 causing
significant impairment in B cell adhesion, migration, bone marrow homing and antibody production. To
understand the underlying molecular mechanisms, we have determined the crystal structure of CD53; in the
entire tetraspanin family, this the first structure captured in an active conformation. We reveal how conformational
changes influence CD53 partner interactions by mass spectrometry (MS) based footprinting. We have used
proximity labeling to identify several candidate CD53 partners, whose functions link chemokine signaling to cell
motility. These data support our hypothesis that CD53 coordinates a complex of adhesion, signaling and cell
motility proteins that facilitate B cell trafficking. Both normal and malignant B cells rely on accurate trafficking to
their niches in the bone marrow and secondary lymphoid organs to optimize their maturation and function. Thus,
an understanding of the interactions that guide B cell trafficking are important not only for optimizing normal B
cell function, but will also reveal potential therapeutic targets of malignant B cells. Using a combination of in vitro
and vivo adhesion and migration studies in combination with proximity labeling, quantitative MS, live-cell MS-
based footprinting, biochemical and electron microscopic analyses, this dual-PI proposal presents a 5-year plan
to: 1) elucidate the CD53-partner interaction network regulating B cell trafficking, and 2) determine the functional
consequences of disrupting the CD53-partner interactions. Armed with our newly developed tools, we will reveal
a novel network of protein interactions coordinating cell signaling and motility to regulate B cell adhesion,
migration, chemokine signaling and niche localization. We will uncover how this CD53-mediated network
responds to chemokine signaling during B cell migration and how cross-cell interactions are established during
B cell homing. Thus, the proposed studies will significantly advance our understanding of how B cell trafficking
is coordinated and regulated. Given the conserved structure and functional redundancy of tetraspanin family
members, this will lead to our long-term goal of elucidating tetraspanin/partner relationships that apply to other
roles of CD53 in immune system function and malignancy as well as the functions of other tetraspanin family
members.

Public health relevance
Project Narrative The proposed research is relevant to public health because the CD53 interaction network regulates normal B cell trafficking and controls immune response and antibody production in humans. This network also facilitates malignant B cell trafficking to bone marrow and lymphoid organs. Thus, understanding the specific functional role of CD53 network and the underlying mechanisms will lead to the better management of normal immune response and to new therapeutic strategies for treating leukemia and lymphoma. .